Using a Joint-Otoacoustic Emission Profile to Detect and Monitor Endolymphatic Hydrops in Humans and to Explore Mechanisms of Pathology

PROJECT SUMMARY/ABSTRACT
Endolymphatic hydrops (EH), a hallmark of Ménière’s Disease, is a cochlear disease caused by either an over-
production or under absorption of endolymphatic fluid. As a result of this excess of endolymph, the membranes
bounding the endolymphatic space are distended outwards. These notable alterations in cochlear morphology
cause disruptions in cochlear mechanics. The early identification and monitoring of EH is critical to preventing
progression of this, oftentimes, debilitating auditory/vestibular disease (which is episodic in nature). Clinical
diagnosis of EH is primarily made via symptomology, with the most reliable diagnostic marker being a fluctuating,
low-frequency sensory hearing loss. EH typically progresses to sensory deficits that no longer recover, resulting
in permanent hearing impairment that can eventually span across the audible frequency range. Therefore, early
identification and monitoring of the disease process is critical to preventing its progression.
Otoacoustic emissions (OAEs) are an ideal monitoring tool. OAEs are low-level sounds measured in the ear
canal that have been shown to gauge cochlear function and dysfunction with high accuracy. Along with recent
advances in this objective, efficient, and noninvasive probe of cochlear function, OAEs have the potential to be
a powerful tool in improving the efficacy of EH diagnosis, given the human cochlea cannot be accessed or
manipulated for direct study. We can now measure two distinct classes of emissions jointly — OAEs arising from
nonlinear distortion (distortion product OAEs) and OAEs arising from coherent linear reflections (stimulus-
frequency OAEs) using rapidly sweeping tones. The purpose of this work is to assess the diagnostic utility of
such a Joint-OAE Profile in identifying and monitoring EH while also exploring the mechanism of disease through
perceptual tests and phenomenological modeling to improve the efficacy of EH diagnosis in humans.
This K01 proposal will first probe cochlear changes during EH using a Joint-OAE profile – a profile comprised of
the two classes of emissions measured and analyzed together to access both generation processes (Aim 1).
Additionally, we will explore the underlying mechanisms of EH by determining whether EH causes shifts in the
cochlear frequency-place map using both a perceptual task (binaural pitch matching between the healthy and
diseased ear within an individual) and physiological measurements of SFOAE latency (or group delay) (Aim 2).
Finally, data collected from Aim 1 and 2 will be directly compared to model predictions that explore the
mechanical effects of EH on the cochlear partition and the consequences for OAE generation (Aim 3).
Combined, this physiological, perceptual, and computational approach to understanding endolymphatic hydrops
is a comprehensive and bold attempt to understand its clinical manifestations and disease timeline, as well as
its underlying mechanisms of pathology.

Public health relevance
PROJECT NARRATIVE Early identification and monitoring of endolymphatic hydrops (EH) is critical to preventing progression of this, oftentimes, debilitating auditory/vestibular disease (which is episodic in nature). Our approach will be to combine an advanced, objective tool our lab has developed (a Joint-Otoacoustic Emission Profile), which characterizes the generation of two separate intra-cochlear responses, with perceptual measurements of pitch, and computational modeling, to improve the efficacy of EH diagnosis in humans, whose cochlea cannot be accessed or manipulated for direct study. This longitudinal approach to understanding EH is a comprehensive and bold attempt to understand its clinical manifestations as well as its underlying pathophysiology, while enhancing the diagnosis and monitoring of disease progression.